Exocytosis of Plasmodium egress and invasion organelles

Project Summary
Human malaria caused by the intracellular parasite Plasmodium falciparum is responsible for nearly
600,000 deaths every year. The clinical symptoms of malaria are caused by the exponential asexual
growth of parasites within human red blood cells. This cycle begins with the invasion of P. falciparum into
the erythrocyte, where it hides within a vacuole (parasitophorous vacuole or PV) to divide into daughter
merozoites and ends with the rapid release of merozoites that invade a red blood cell (RBC) to start the
cycle anew. The egress and invasion of merozoites requires the signal-dependent exocytosis of
specialized vesicles known as exonemes into the PV during egress and organelles known as rhoptries
into the RBC during invasion. Data show that intracellular calcium oscillations lead to exocytosis of both
exonemes and rhoptries within minutes of each other. But it is not known how the exocytic machinery on
exonemes and rhoptries differentiate between the two intracellular calcium oscillations. It is likely that the
proteins responsible for exocytosis are differentially sensitive to calcium and hence, respond differentially
to the varied calcium signals during egress and invasion. However, the proteins localized in the secretory
pathway required for signal dependent exocytosis remain mostly unknown. Therefore, we took a
bioinformatic approach to identify several proteins in the secretory pathway with calcium binding domains
that we hypothesized to function in organelle discharge during Plasmodium egress and invasion. This
approach led to the identification of a calcium binding protein (PfERC) with an essential role in P.
falciparum egress. Based on these published data, we wanted to test if PfERC functions in exoneme
exocytosis but organelle discharge during egress or invasion has never been observed in live parasites.
In the first aim, we developed fluorescence microscopy-based assays to investigate signal-dependent
exoneme exocytosis and we will develop assays to assess calcium oscillations during egress of live P.
falciparum. In PfERC conditional mutants, these live microscopy assays show that PfERC knockdown
inhibits exoneme exocytosis. Using a quantitative proteomic approach, we have identified PfERC
interactors and generated conditional mutants for prioritized candidates. Another candidate, rhoptry neck
protein 11 (RON11), is essential for merozoite invasion. Therefore, in the second aim, we will focus on
P. falciparum invasion and the proposed research will lead to the development of reporters to study
rhoptry discharge as well as calcium oscillations in live merozoites during invasion. Using these assays,
we will test the function of RON11 in rhoptry discharge, calcium oscillations as well as merozoite invasion
into the RBC. The proposed research will identify several putative targets for antimalarial drug
development. Since organelle secretion is required for egress and invasion of Plasmodium parasites
during all stages of their lifecycle, this research may lead to the identification of pan-active antimalarials.

Public health relevance
Project Narrative The obligate intracellular parasites from the genus Plasmodium grow within human red blood cells, causing a lethal disease called malaria. The proposed research aims to understand the parasite-specific pathways required for egress from and invasion into the red blood cells as well as host cells in other stages of the Plasmodium life cycle. The proposed study will help us identify targets for novel, pan-active antimalarial therapies, which are sorely needed because Plasmodium has developed resistance to all currently available antimalarial drugs.